Muscle Power as a Predictor of Knee Osteoarthritis in At-Risk Females

Project Summary
The Centers for Disease Control and Prevention estimate that 26% of Americans aged ≥ 18 years will suffer
from arthritis by the year 2040. Osteoarthritis (OA) is the most common form of arthritis, with the knee joint being
the most commonly affected weight-bearing joint. With no cure on the horizon, it is imperative that preventing
knee OA is a health initiative. While risk factors such as age, biological sex, and obesity are well-defined,
neuromuscular capabilities are generally neglected in predictive models of incident knee OA. Muscle power (the
product of muscle force and muscle shortening velocity) is strongly related to healthy aging in a knee OA
population. Maximal muscle power is more strongly correlated to pain and mobility than muscle strength in
individuals with knee OA and is significantly associated with a variety of important mobility assessments including
walking and sit-to-stand tasks.
This ancillary study leverages the patient cohort, data, and resources at baseline and 48-month follow-up of The
Osteoarthritis Prevention Study (TOPS) parent randomized clinical trial. The parent trial is nearing the end of
year 1 of a 5-year grant period; recruitment began in January 2024, and the first participant was enrolled in March
2024. Maximal knee extensor muscle power measures at baseline will be added to a subsample of participants
(N = 159) randomized to the attention control group of the parent grant. The primary aim of this ancillary study
is to determine whether the incidence of structural knee OA, defined by MRI Osteoarthritis Knee Score (MOAKS),
is predicted by baseline levels of maximal concentric isotonic knee extensor muscle power in a female cohort at-
risk for developing knee OA. Secondary aims will determine whether incident structural knee OA is predicted by
baseline levels of sit-to-stand task performance and countermovement jump performance, surrogate measures
of muscle power that can be administered in a clinical setting. A mechanistic aim will determine whether
decrements in knee-joint muscle torque and/or knee-joint angular velocity, factors that determine muscle power,
underpin low muscle power and predict incident knee OA in women at high risk for developing knee OA.
This ancillary study will contribute novel data regarding a potential mechanistic pathway to incident knee OA, the
leading cause of disability in adults. To accomplish our specific aims, we will leverage indices of structural (MRI)
OA at baseline and 48-month follow-up from the parent trial and add baseline laboratory (dynamometry) and
clinical (sit-to-stand and countermovement jump) measures of muscle power, the latter two that can be easily
measured in the clinic. This information could help clinicians identify patients at high risk for this disabling disease
by potentially using simple muscle power assessments that can be performed in clinical settings.

Public health relevance
Project Narrative Muscle power is a comprehensive assessment of muscle function incorporating both muscle force and muscle kinematics. This ancillary study will test the novel hypothesis that muscle power is predictive of incident knee osteoarthritis (OA) in a high-risk population, which has not been previously investigated and can be evaluated in the clinic. By establishing that greater muscle power is predictive of less incident knee OA, health care providers can encourage individuals at-risk for knee OA to include muscle power development in their exercise prescription.